Curriculum Development Using Big Data for Cancer Prevention and Control

Abstract
To reduce the burden of cancer among U.S. populations, the NCI, Centers for Disease Control and Prevention
(CDC), and other agencies rely on networks of academic, governmental, and community partners to take action
in cancer control and education. The range of activities undertaken by community-based organizations (CBOs)
is broad and may encompass prevention and screening; diagnosis; treatment; survivorship care; and quality of
life for cancer patients and families. The success of these initiatives focuses on precise assessment of
community priorities, design and implementation of strategies to address the priorities among their communities,
and dissemination and evaluation of evidence-based interventions. Most communities draw from extensive
publicly available national datasets that provide details to the county level in each state and serve as the basis
for CBO “action plans”, to develop how health equity will be achieved and cancer disparities reduced. Accurate
identification and use of national, state, and county data are vital and rely heavily on such organizational capacity
in the application of large population-based datasets (Big Data). However, using and applying these large
datasets and interpreting data findings are not easily accomplished by CBOs, particularly in rural settings.
Currently, no curricula exist aimed at educating and supporting CBOs' engagement with Big Data for cancer
program priority assessment, design, and implementation. We hypothesize that developing a unique, essential
curriculum designed to train cancer CBOs in Big Data use and application for cancer programs will close this
training shortfall, enhance community program quality, and improve population outcomes. To address the stated
gaps in the literature and in practical tools to assist cancer CBOs, our Goal is to develop and test a curriculum
specifically focused on Using Big Data for Community-Based Cancer Control and Education Programs (BigC3E).
The Specific Aims are to: 1) develop a novel curriculum with high potential to improve biomedical, behavioral
and/or clinical cancer education targeting members of the lay community involved in the dissemination of health
information; 2) test the feasibility, acceptability, and suitability of content with stakeholder members of two large
regional Cancer Coalitions in Georgia, and 3) prepare for broad dissemination of the curriculum nationwide. The
proposed BigC3E curriculum, including content, delivery, and experiential, problem-based learning approach, is
highly innovative and its successful implementation and dissemination would impact community-based cancer
control and education programs on a major scale nationwide. Detailed curriculum development and testing
methods are proposed, including a robust Evaluation Plan, in partnership with two established community cancer
coalitions in Georgia, representing 68 counties and over 200 stakeholders, to contribute to the project's
curriculum development, testing, and plans for dissemination. This program will provide the foundation for
communities nationwide to enhance their cancer control and education work to fulfill the NCI mission of
advancing and distributing scientific knowledge and improving cancer outcomes throughout the U.S.

Public health relevance
Narrative This proposal will develop, test, and prepare for dissemination a novel online curriculum intended to train community-based cancer organizations how to use diverse types of population-level Big Data to improve needs assessment, program planning, and education for patients and the public in their communities.